Texas Animal Feed Regulatory Program Standards Maintenance and Mutual Reliance

Abstract: Texas Animal Feed Regulatory Program Standards Maintenance and Mutual Reliance
The Office of the Texas State Chemist (OTSC) is the designated state agency that oversees the regulation
of animal feed including sample analysis. Specifically, OTSC is comprised of the Texas Feed and Fertilizer
Control Service (FFCS) which is the regulatory agency and the Agricultural Analytical Service (AAS) which
analyzes regulatory samples for FFCS and the Food and Drug Administration. During the past 5 years,
OTSC maintained the eleven standards, maintained ISO 17025:2017 accreditation, improved and updated
its document management system and is utilizing the system for AFRPS implementation. During the next
3 years, OTSC will participate in regularly schedule meetings, participate in collaborative regulatory
activities with FDA and state animal food regulatory programs. Maintain implementation with the current
AFRPS, will participate in scheduled assessments by the FDA Audit Staff of the AFRPS, provide meeting
space and accessibility of staff and access to records, databases, and other materials that support the
implementation of the AFRPS. OTSC will contribute to the continuous improvement of the AFRPS through
attendance at an annual face-to-face meeting and actively participate in these and other exchanges. OTSC
will integrate AFRPS with its LFFM program involving analyzing samples within its ISO 17025-2017 scope,
achieve compliance with violative samples using AFRPS procedures and collaborate with FDA and other
states in this process. OTSC is not currently part of the RRT program funded by FDA but continues to
participate in this program and to the extent practicable, will utilize RRT procedures and methods for
activation of the RRT. OTSC will use the necessary regulatory and compliance response infrastructure to
investigate and respond to violative samples, including qualified personnel, IT resources, and regulatory
authorities. OTSC will perform an annual estimate of the capacities and capabilities for animal food sample
collection and analysis for chemical and microbiological hazards for emergency response, surveillance
and compliance efforts. OTSC will expand the number of qualified field investigators who can perform
comprehensive inspections as a participant in the mutual reliance program and will move to phase 3 of
performing inspection audits. OTSC will participate with FDA in the planning of state audits performed by
qualified investigates who will perform comprehensive inspections based on risk and inspection frequency
in conjunction with planning FDA contract audits. This activity will include sharing facility inventories,
provide date involving state audits and follow the Compliance Program Guidance Manual (CPRM
(7371.000). State inspections may involve investigating SAHCODHA hazards based on data such as
recalls, complaints, and Reportable Food Registry reports, outbreaks and other information. OTSC has a
current 20.88 Agreement signed by Debra A. Cummings May 10, 2024.

Public health relevance
Narrative: Texas Animal Feed Regulatory Program Standards Maintenance and Mutual Reliance During the next 3 years, OTSC will maintain adherence to AFRPS through a number of activities that include: building a more robust facility risk ranking matrix and analysis platform, expanding audit capability from one to two auditors and enter phase 3, utilizing feed-related illnesses or death data in the risk ranking matrix and identifying/performing state comprehensive inspection under the mutual reliance program track, continue to evaluate industry compliance through the enforcement matrix, and incorporating Laboratory Flexible Funding Model program samples into the OTSC annual plan of work. OTSC will expand the number of qualified field investigators who can perform comprehensive inspections to seven for contract and an additional 6 investigators who can conduct comprehensive inspections under state authority.